Microbial Determinants of Acute Respiratory Distress Syndrome Severity (MiDAS)

PROJECT SUMMARY – ABSTRACT
The Acute Respiratory Distress Syndrome (ARDS) is a serious form of inflammatory lung injury that disrupts
the alveolar/capillary membrane leading to pulmonary edema and low oxygen levels. Despite advancements in
understanding lung injury mechanisms, clinical trials for targeted pharmacologic therapies have shown limited
efficacy, and care remains mostly supportive. Notably, most patients with ARDS do not die from hypoxemia but
from multisystem organ failure, but the mechanisms of extrapulmonary organ damage are poorly defined. The
clinical significance of ARDS was evident in the pre-pandemic era, accounting for 10% of ICU admissions, with
up to 40% mortality and long-term sequelae to survivors, yet it has become a global emergency during the
COVID-19 pandemic. Recent research has uncovered two reproducible ARDS subphenotypes (hyper- vs.
hypo-inflammatory), with distinct profiles of systemic inflammatory biomarkers and divergent clinical outcomes.
Despite the promise of this stratification framework for targeted therapeutics, ARDS subphenotypes are not
currently used for therapeutic guidance and their biological underpinnings are unknown. Emerging work from
our group highlights the lung microbiome as an underappreciated determinant of ARDS inflammation and
clinical outcomes. Beyond the lungs, we have also discovered provocative associations between circulating,
plasma microbial fragments (i.e. nucleic acids and cell-wall constituents) with host inflammation and outcome.
Such microbial fragments may leak in the systemic circulation through the disrupted alveolar/capillary
membrane and act as pathogen associated molecular patterns that stimulate innate immune cells. However,
the extent and impact of microbial translocation in ARDS has not been thoroughly studied. In the proposed
Microbial Determinants of Acute Respiratory Distress Syndrome Severity (MiDAS) study, we will leverage
culture-independent methods of host-microbiota interactions in two body compartments (lungs and blood) in a
well-phenotyped cohort of patients with and without ARDS, to accomplish the following specific aims: 1) To
define the clinical and molecular determinants of lung microbiota translocation to the blood, and 2) To derive
lung and blood compartment subphenotypes of host-microbiota interactions in ARDS. The MiDAS study will
advance our understanding of the role of the lung microbiome in ARDS and clarify whether microbial
translocation from the injured lungs of ARDS is an innocuous epiphenomenon or a significant pathogenetic
contributor. With rapid and informative subphenotyping of ARDS patients by host-microbiota interactions, our
approach has the potential to transform the practice of indiscriminate immunomodulatory therapies to timely,
personalized regimens tailored to individual patients’ pathogens and inflammatory status.

Public health relevance
PROJECT NARRATIVE Critically ill patients with acute respiratory distress syndrome and intensified systemic inflammation have poor clinical outcomes, but we lack understanding of the biological determinants of dysregulated inflammatory responses. Recent data highlight the role of lung microbiota in determining the host inflammatory response in critical illness. In this proposal, we will leverage culture-independent methods for study of host-microbiota interactions in both the lung and blood compartments to derive a novel framework for subphenotyping critically ill patients and guiding precision management approaches.